The Texas Resource Center on Minority Aging Research (RCMAR)

REVISED ABSTRACT:
The purpose of the Texas RCMAR Analysis Core (AnC) is to promote and facilitate studies of aging in populations of Texas, the Southwestern United States, and Mexico. We focus on using longitudinal data from survey datasets to better understand migration and aging health among older adults in the US and Mexico, in relation to social, psychological, and behavioral factors. The AnC will provide services and expertise in research design, measurement, data management, and both quantitative and qualitative analysis to Texas RCMAR Scientists, and will serve as a resource for mentors for those conducting pilot research. The AnC will provide monthly seminars on available data and workshops on longitudinal data analysis and innovative analytical methods. The AnC includes biostatisticians, epidemiologists, gerontologists, sociologists, and demographers well known in aging studies: statistical analysis of longitudinal data on aging (Yu), frailty and rehabilitation (Al Snih), social determinants of health and aging (Hill), mixed method study design and qualitative analysis (Nicklett), and aging health outcomes research using large administrative data (Kuo). AnC specific aims are: Aim 1. Provide measurement, statistical, and methodological support for pilot research designed to increase the number of faculty conducting research on population aging and health . 1.a. Cooperate with the Research Education Component (REC) to participate in the design, monitoring, data management, and statistical analysis planning for pilot research projects. 1.b. Provide analytical mentoring to Texas RCMAR Scientists. Aim 2. Collect, disseminate, maintain, and update infrastructure on sources of data relevant to aging, and measurements of social determinants of health to all Texas RCMAR investigators. 2.a. Establish resources on population-based datasets for aging research through centralized online system and monthly seminars. 2.b. Document and disseminate measurements of social determinants of health. 2.c. Coordinate data extraction and analytical file generation for aging investigators and provide statistical consultation especially with respect to multilevel and longitudinal data analysis. Aim 3. Develop, present, and disseminate instruction in advanced analytical methods for Texas RCMAR Scientists and other RCMAR affiliates. 3.a. Develop and provide a biannual 2- day longitudinal data analysis workshop and an annual one-day workshop on applying innovative analytical methods on behavioral and social science research. This workshop series will cover a range of topics, including modeling and publishing quantitative results, machine learning in social science, mixed methods, and causal inference in the social sciences. 3.b. These new training materials and resources will be disseminated to the broader network of researchers in gerontology, geriatrics, and other disciplines to foster research on population aging and health. Thus, the Texas RCMAR AnC will be a national resource supporting research in aging and health.